EFFECT OF GROWTH HORMONE ADMINISTRATION ON GONADAL FUNCTION IN HEALTHY OLDER MEN

We will test the hypothesis in older men that reduced serum androgen concentrations result from GH deficiency in aging. To this end, we will conduct a randomized blinded trial of GH administration.